Designing a Comprehensive Machine Learning-driven Prescriptive Clinical Decision Support System for Shock and Associated Critical Care Conditions

Title
Designing a Comprehensive Machine Learning-driven Prescriptive Clinical Decision Support System
for Shock and Associated Critical Care Conditions
PI: Yoon, Joo Heung (University of Pittsburgh)
Abstract
The thought process of intensive care unit (ICU) clinicians to make everyday decision is quite complex with a
lot of concurrent acute and chronic clinical conditions to consider, which requires challenging risk-stratification
and prioritization steps among competing interests and confounders. Also, those decisions are high-stake and
need to be timely.
With the recent advancement of machine learning in medicine, various diagnostic and therapeutic models were
attempted in hope of streamline those decision-making processes. However, most of machine learning (ML)
models cannot be readily implemented to bedside, with less than 5% of models have gone through appropriate
prospective study or clinical trials. The challenges are, i) inefficient ML model development pipeline with
incomplete data, repetitive workflow with pre-processing, labeling, and featurization, all of which are extremely
resource intensive, ii) the lack of overarching decision supporting engine that handles competing interests
among simultaneous different decisions, and iii) inadequate post-implementation analysis with unclear safety
profile of using ML models at bedside. Through this Maximizing Investigators' Research Award proposal, we
will focus on resolving those critical bottlenecks in ML-driven decision support strategy, with the example of
shock and associated critical condition, which are very frequently encountered among critically ill patients.
First, to address the efficient and approachable ML model design, we will develop a multimodal foundation
model for ICU patients. Self-supervised pre-trained models using a large amount of various clinical data, using
waveform and electronic health record (EHR). Second, by using the foundation model, we will generate a
series of downstream detection, prediction, and management models in a very time-efficient way. Then we plan
to build a dynamic priority engine to determine next set of actions prior and during the shock period, through
which the treatment priorities will be determined by the importance and urgency of each clinical problem using
reinforcement learning, based on the inference generated by downstream models. Just like real-life clinical
decisions are changing with time, the priority set by our engine will change as well. Third, we will silently deploy
the priority engine to the data stream of deidentified ICU patients, in which setting neither clinicians nor
patients will aware the model's presence as it only runs in background and the detection, prediction, or
management plans will not be shared, but available for outcome analysis. After the completion of this proposal
period, we ultimately plan for a scalable multi-center clinical trial on our downstream models and prioritization
engine for shock and other condition management. We will make the entire models, pipeline, and results
publicly available. Current proposal will set a roadmap for implementable ML-driven clinical decision support
system for researchers and clinicians to utilize in critical care environment.

Public health relevance
PROJECT NARRATIVE Machine learning-driven complex decision making to manage shock and other critical care conditions are challenging with its resource-intensive development pipeline and conflicting decisions. Our goal is to navigate this process with leveraging multimodal foundation modeling to gain efficiency, creating a priority engine to streamline complex decisions, and safely simulating this in data stream through silent deployment.